Metabolic Regulation of Glioblastoma Epitranscriptomics

ABSTRACT
Glioblastomas rank among the most lethal of all human cancers. Current standard-of-care therapy for
patients afflicted with glioblastoma offers only palliation. Treatment failure derives from numerous causes,
including the presence of stem-like tumor cells, called glioblastoma stem cells (GSCs). GSCs contribute to
radioresistance, chemoresistance, invasion, immune escape, and angiogenesis. Previously, we reported that
critical nodes in methyl donor metabolism and methyl utilization ranked among the most consistently
overexpressed pathways in glioblastoma relative to normal brain. Targeting methyl donor metabolism
expression reduced cellular proliferation, self-renewal, and in vivo tumor growth of GSCs. Thus, methyl donor
metabolism is a promising GSC-specific therapeutic target in glioblastoma that would result in disrupting
oncogenic DNA hypomethylation. In preliminary studies, we have extended our efforts to bridge metabolic
reprogramming in glioblastoma with maintenance of stemness through regulation of epitranscriptomics to
identify metabolic and molecular targets that are preferentially active in GSCs. Leveraging a combination of
genetic and pharmacologic inhibitors, we have identified key regulators that manifests as altered
epitranscriptomic methylation events to maintain GSCs.
In the proposed studies, we will interrogate the functional contributions of selected metabolic enzymes in
oncogenic metabolite production and reprogramming of the tumor cell state to maintain stemness. We will
investigate the metabolic control of cell state through the metabolites generated or lost in GSCs and then
define the specific molecular regulators responsible, including a focus on stemness mediators. In preliminary
studies, we find that altered metabolism in GSCs induces alterations in the post-transcriptional regulation of
mRNAs that shift the RNA profiles towards a stem-like state. We now seek to understand the metabolic and
epitranscriptional regulator underlying these observations to determine the molecular regulation of highly
malignant tumor cell populations and support the development of better therapeutic interventions. Moreover,
epitranscriptomics may serve as a pharmacodynamic measure of selected targeted therapeutics and that
target metabolically regulated epigenetic modulators.
To translate these efforts into proof-of-principle novel preclinical paradigms, we are using agents that target
metabolic targets and epitranscriptomics. These small molecule inhibitors can potentially be combined with
other therapies to create therapeutic paradigms for glioblastoma. To generate the most effective therapeutic
model, we will interrogate the preclinical utility of novel targeted therapies that disrupt the metabolic and
epigenetic reprogramming with potential to accentuate the efficacy of conventional therapy. Collectively, the
proposed studies will lay the foundation for improved understanding of metabolic reprogramming in cancer
stem cell biology with possible translation to improved oncologic care.

Public health relevance
PROJECT NARRATIVE Glioblastoma ranks among the deadliest of all human cancers, with current therapies offering only palliation. In this research project, we will study a novel regulation of brain tumor cells that resemble stem cells and are often resistant to radiation and chemotherapy. Cellular metabolism and regulation have been reprogrammed by these brain tumor stem-like cells, revealing potential new treatments for patients afflicted with glioblastoma.